Mitotic transmission of acentric chromosomes

The goal of this proposal is to elucidate the mechanisms that maintain genome integrity during anaphase and telophase.
These are particularly perilous phases of the cell cycle, requiring separation and segregation of replicated sister
chromosomes and their incorporation into newly formed daughter nuclei. Failure to completely and accurately separate the
duplicated genome during these phases can lead to cancer development or cell death. However, while much work has been
devoted toward elucidating the mechanisms that maintain genomic integrity during interphase and metaphase, less attention
has been paid to the mechanisms that operate specifically during anaphase and telophase. One reason for this knowledge
gap is that the prevailing view has been once checkpoints acting prior to anaphase are satisfied, anaphase and telophase
proceed rapidly without error correction mechanisms. However, work over the past decade from our lab and others have
upended this traditional view to reveal that the eukaryotic cell maintains a sophisticated and diverse set of mechanisms that
function during anaphase-telophase to maintain genomic integrity. Our entry into this field originated from live observations
of Drosophila neuroblasts. We discovered that chromosome fragments lacking a kinetochore (acentrics) successfully
congress, undergo delayed but proper sister separation, efficiently segregate to opposing poles and incorporate into daughter
nuclei well after nuclear envelope assembly. This was unexpected as all of these chromosome dynamics were thought to
be largely driven by kinetochore-microtubule interactions. Our past studies have revealed a number of cellular adaptions
such as protein-coated DNA tethers, cell and spindle elongation, and channels in the telophase nuclear envelope that ensure
accurate acentric segregation and incorporation into daughter nuclei. During this last period of MIRA funding, we built
upon this knowledge by determining that acentric sister separation is driven by plus-end-directed microtubule forces. We
also acquired evidence that acentric poleward segregation relies on actin-based processes. Additionally, we characterized
previously undescribed mechanisms such as ubiquitous DNA threads between separated sister and non-sister anaphase
chromosomes that promote acentric rescue. Finally, we gathered preliminary evidence suggesting that these
anaphase/telophase adaptations promoting acentric chromosome segregation exist and operate in human cells. The future
Drosophila and mammalian cell line studies described here will determine the molecular underpinnings of these unexpected
mechanisms operating during anaphase-telophase to preserve genome integrity through a combination of genetic,
fluorescent and electron microscope studies as well as biochemical approaches. Additionally, we will apply our expertise
in chromosome biology to elucidate the mechanisms by which the insect endosymbiont Wolbachia disrupts host
chromosome segregation in order to promote its transmission through wild populations. All of these studies provide
excellent opportunities for undergraduates, especially URM students to receive mentored hands-on lab experiences often
leading to co-authorship on peer reviewed publications.

Public health relevance
Project Narrative Cells maintain sophisticated mechanisms that ensure replicated chromosomes are accurately transmitted to daughter cells during division. When these mechanisms fail, cancer and other diseases are the result. The studies described in this grant examine an unsuspected and unexplored set of mechanisms that operate during the final stages of cell division (anaphase/telophase) to ensure accurate chromosome transmission.